Administrative Core

Abstract
The administrative core of the PO1 will be in charge of optimizing communications between PIs, their
administrations, the members of their labs, the steering committee, and the NIH. In addition, this core will be
administering the financial resources of the consortium by communicating with the offices of sponsored programs
of each participating institution. This multipart organization relies on experienced administrators who efficiently
set up virtual meetings, set and respect deadlines, organize the annual meeting and the annual report to NIH,
and have the initiative to communicate efficiently through email conversations with members of the group. The
Administrative Core (AC) will have four specific tasks, all of them converging to facilitate the communication
between investigators of the group and their staff.
Task 1: Overall organization, coordination of the multi-investigator project and report to NIH.
We have formulated a management plan to facilitate and optimize the six groups involved in the project. The
overall goal of this plan is to make certain that milestones are achieved in a timely manner within the proposed
fiscal plan. Monthly e-meetings will be critical to achieve these goals.
Task 2: Communication with NIH.
For any urgent matter related to the PO1, the P.O. will be contacted directly by phone and/or e-mail. The
Administrative Core Leader will be in charge of all communication with NIH officials.
Task 3: Assemble a consultative External Scientific Advisory Group.
An External Scientific Advisory Group (ESAG) will be assembled and have three members. The ESAG will
participate to our annual meeting and review the Research Plan objectives.
Task 4: Establish and maintain the PO1 Website.
The Website will be designed and put on-line as soon as the notice of award is received. This Website will be
organized for inside and outside access with restrictions for outside users only. This portal will allow us to
communicate and establish collaborations with the wider scientific community.
In addition, for day-to-day communication an internal Slack channel will be created and used to share protocols
and results.